Flupirtine Analogue Synthesis and Screening for the Treatment of Chemotherapy-Induced Neuropathic Pain

PROJECT SUMMARY
Chemotherapy-induced neuropathic pain (CINP) is a common side effect for cancer patients and can greatly
reduce patients’ quality of life. Although a wide range of pharmacological agents have been investigated in
clinical trials as potential CINP therapies, currently approved analgesics for neuropathic pain are inadequate
and offer limited beneficial effects in ameliorating CINP. Flupirtine, a non-opioid and non-steroidal anti-
inflammatory drug analgesic, can effectively relieve various pain conditions in clinical studies. However, safety
concerns, particularly rare but severe liver toxicity, led to restrictions on its use and eventual withdrawal from
the market in the U.S. The adverse side effects of flupirtine that induce hepatotoxicity have been shown to not
be linked with the primary antinociceptive mechanism of action. We have developed a flupirtine analogue
library and demonstrated that one of the compounds (compound 5) had a much faster metabolism rate than
the flupirtine parent and did not induce hepatotoxicity after intraperitoneal injection. We have also successfully
developed both short-term and long-term mouse CINP models. Our results showed that compound 5
effectively ameliorated short-term CINP, as evidenced by various pain behavior tests. In this proposal, we will
further synthesize and screen flupirtine analogues through structural modification to enhance their liver safety
profile while maintaining or even improving therapeutic efficacy to effectively relieve CIPN. The specific aims of
the studies are (1) to strategically develop potent Kv7.2/7.3 activators unable to form hepatotoxic metabolites,
(2) to determine the analgesic efficacies of flupirtine analogues in the CINP mouse models. This proposal will
develop a series of novel flupirtine analogues with reduced or eliminated hepatotoxicity as non-opioid
analgesics to relieve CINP and treat various other pain conditions and non-pain-related diseases.

Public health relevance
PRPJECT NARRATIVE Chemotherapy-induced neuropathic pain is a frequent side effect experienced by cancer patients and can significantly diminish their quality of life. Flupirtine, an effective non-opioid and non-steroidal anti-inflammatory drug analgesic for various pain conditions, has faced restrictions and market withdrawal due to safety concerns regarding hepatotoxicity. This proposal aims to synthesize and screen a series of novel flupirtine analogues to reduce/eliminate liver toxicity while maintaining/improving chemotherapy-induced neuropathic pain relief capacity.